Brainstem glial senescence and dysfunction in obesity-induced hypertension

Elevated sympathetic nerve activity (SNA) mediates the increased risk for hypertension and heart failure
in obesity. Yet the mechanisms that contribute to obesity-induced increases in SNA remain unclear. Our lab has
previously demonstrated a critical role for oxidative stress in the RVLM, a key brainstem region that regulates
sympathetic outflow, in obesity-induced sympathetic overactivity. Although RVLM neurons responsible for
sympathetic control of cardiovascular activities have been studied extensively, little or no attention has been paid
to their non-neuronal neighbours, astrocytes and microglia. Exciting preliminary studies from our lab suggest
that astrocytes and microglia in the RVLM display distinct phenotypical changes in response to chronic oxidative
stress in obesity. We provide novel evidence that microglia in the RVLM are most vulnerable to undergo
senescence, a stress response that significantly alters cellular phenotypes and potentially contributes to
inflammation through senescence-associated secretory phenotype (SASP). On the other hand, obesity impairs
astrocytic glutamate reuptake transporter activity (EAAT2) and enhances extrasynaptic glutamate excitatory tone
in the RVLM. In addition to these cell-autonomous mechanisms, our exciting preliminary studies indicate that
soluble factors secreted from senescent microglia negatively regulate astrocytic EAAT2 expression, indicating
potential crosstalk between senescent microglia and astrocytes in the RVLM as another likely mechanism for
obesity-induced sympathoexcitation and hypertension. Guided by strong preliminary data and published studies,
we will test the following hypothesis that obesity causes glial dysfunction in the RVLM marked by microglial
senescence and impaired astrocytic glutamate reuptake transporter activity. The resulting neuroinflammation
and increased glutamate excitatory tone in the RVLM contribute to increases in blood pressure and SNA in
obesity. In aim 1, we will determine the mechanistic role of senescent microglial cells and their secretory
phenotype on SNS overactivity and hypertension in obesity. In aim 2, we will determine the mechanism by which
astrocytic dysfunction in the RVLM contributes to sympathoexcitation and hypertension in obesity. In aim 3, we
will determine the role of microglia-astrocyte interaction in obesity-induced sympathoexcitation. We will use an
array of novel transgenic mice models (targeted senescence induction and elimination), cell-type-specific gene
delivery techniques, state-of-the-art radiotelemetry for continuous monitoring of cardiovascular parameters in
conscious mice, cutting-edge proteomics, lipidomics and single-cell sequencing approaches to accomplish the
proposed aims. Overall, our studies will shed light on the often-overlooked glial mechanisms and offer new
therapeutic targets (senolytics and EAAT2 activators) for the prevention or treatment of hypertension in obese
individuals

Public health relevance
The economic and social impact of obesity has reached an all-time high of almost 1.4 trillion dollars in 2018, of which 40% is attributed to cardiovascular diseases. The current proposal will address a novel central mechanism that could be pharmacologically targeted for reducing or preventing the heightened risk for cardiovascular diseases in obese individuals.